Novel imaging biomarkers of neuroinflammation in Alzheimer's disease

Abstract
Alzheimer's disease (AD) is a widespread global neurodegenerative disorder, accounting for the majority of
dementia cases in the United States. With over 25 million people affected by the disease, this number is expected
to double by 2050, primarily due to the growing aging population. The amyloid cascade hypothesis posits that
the accumulation of amyloid-β in the brain triggers AD. However, the complexities of AD pathogenesis extend
beyond this theory, with mounting evidence linking inflammatory markers and AD risk genes to innate immune
functions, emphasizing the significant role of neuroinflammation. This study aims to develop and optimize
noninvasive imaging biomarkers to track neuroinflammation in the early stages of AD and explore the intricate
connections between neuroinflammation, brain glucose hypometabolism, and the progression of AD.
The study proposes the use of deuterium-magnetic-resonance-spectroscopy (DMRS) and quantitative-
exchanged-label-turnover MRS (qeltMRS) with deuterium-labeled acetate to track the temporal dynamics of
neuroinflammation in AD. The research comprises three specific aims. Firstly, it focuses on investigating the
relationship between astrocytic acetate metabolism and astrocyte reactivity in an adenovirus-induced reactive
astrogliosis model, utilizing DMRS and qeltMRS. The hypothesis suggests a higher uptake and metabolism of
acetate in reactive astrocytes, correlated with increased expression of the monocarboxylate transporter (MCT1)
protein. Secondly, the study aims to characterize the spatiotemporal patterns of neuroinflammation and brain
glucose hypometabolism in an AD mouse model, using DMRS and qeltMRS. The hypothesis proposes that in
AD mice, reactive astrocytes and microglia will metabolize acetate predominantly over glucose, with upregulated
MCT1 transporters and downregulated GLUT3 transporters compared to age-matched WT mice. Lastly, the
research seeks to validate the efficiency of the methods by assessing the impact of a ketogenic diet on
neuroinflammation in AD mice over a longitudinal study. The hypothesis anticipates a slower level of
neuroinflammation in the treated AD mice compared to the untreated group.
The innovation and potential impact of this research lie in providing a robust preclinical framework for
understanding AD pathophysiology, enabling the detection of early pathological processes in vivo. Successful
outcomes may contribute to the development of prognostic tools and personalized treatment strategies targeting
neuroinflammation, ultimately translating findings into clinical applications for improved outcomes in human
patients affected by AD.

Public health relevance
Narrative: The role of neuroinflammation in Alzheimer's disease (AD) pathogenesis has been increasingly recognized as a crucial component in understanding the development and progression of the disease. This proposal will develop and validate noninvasive imaging biomarkers of neuroinflammation using a mouse model that recapitulate human AD. Results from this work will provide an improved mechanistic understanding of the role of neuroinflammation in AD pathogenesis and lead to clinically translatable biomarkers for better diagnosis and management of neuroinflammation that occur in patients with AD.